Function of Steroid Receptors in Subcellular Compartments

The cohesin complex is central to chromatin looping, but mechanisms by which these long-range chromatin interactions are formed and persist remain unclear. We discovered that interactions between a transcription factor (GR) and a multimeric complex, including the cohesin loader NIPBL and cohesin, regulate enhancer dependent gene activity. We demonstrated that the glucocorticoid receptor stabilizes the cohesin complex at GR enhancers, promoting loop extrusion and long-range gene regulation. Follow up experiments suggest that the androgen receptor (AR) also interacts with a similar complex for long range gene regulation. Structural studies are underway to probe the nature of the steroid receptor interactions with the cohesin complex.